Lysosome homeostasis in aging-related diseases

Abstract
Lysosomes are important for maintaining cellular health and their dysfunction is linked to numerous aging-related
diseases. Lysosome function is regulated by homeostatic mechanisms that allow cells to sense lysosomal stress
and either eliminate or repair damaged lysosomes, or generate new lysosomes through transcriptional activation.
Our research has shown that lysosomal stress is sensed through a mechanism that involves the direct
modification of lysosomal membranes by autophagy proteins called ATG8s, through a process called
Conjugation of ATG8s onto Single Membranes (CASM). This mechanism coordinates the turnover of damaged
lysosomal membranes through microautophagy with the biogenesis of new lysosomes, but how these different
activities are balanced to maintain lysosomal health is not well understood. We have shown that membrane
turnover and biogenesis are regulated through separable mechanisms, and that the induction of biogenesis,
which occurs through activation of the transcription factor TFEB, occurs only at particular stress thresholds that
engage turnover across a lysosome network. The long-term goal of this research program is to elucidate how
lysosomal stress is mitigated by lysosome turnover and biogenesis and to uncover how these activities are
balanced to maintain lysosomal health. In my predoctoral research (Aim 1), I propose to test the hypothesis that
lysosome biogenesis is coordinated with turnover by a threshold mechanism that engages biogenesis only at
significant levels of stress, and I will seek to uncover this regulation in neurons and other cell types. Specific
Aim 1.1 will determine how biogenesis is activated by stress thresholding in response to signaling through
CASM, and Specific Aim 1.2 will explore this mode of regulation in normal and diseased human cortical and
dopamine neurons. My postdoctoral research (Aim 2) will study organelle stress signaling and mechanisms of
biogenesis in aging-related neurodegenerative or other diseases using physiologic models like iPSC neurons
and also animal models like mouse or even fish. Overall, these two projects will uncover significant new insights
into the cellular dysfunctions that underlie the development of aging-related diseases, and will reveal new
knowledge about how lysosome function can be maintained or even restored in aging or diseased cells. The
research and training plan outlined in this proposal will be completed with the mentorship of Dr. Michael
Overholtzer at the Memorial Sloan Kettering Cancer Center (MSK) along with a collaborative team that has the
expertise to support the proposed studies. MSK's world class research environment and abundant resources in
conjunction with the support of the Weill Cornell Graduate School will guarantee the successful completion of
the proposed research and career development plans.

Public health relevance
Project Narrative Lysosomes become dysfunctional during aging and this is linked to the development of numerous diseases including many adult-onset neurodegenerative conditions. My studies are uncovering how lysosome function can be restored through mechanisms that remove dysfunctional lysosomes and generate new ones. This research is critical to understanding the origins of aging-related diseases and to uncovering new therapeutic opportunities.